Immune sensing of ischemic injury and complement-dependent modulation of alloimmunity in cardiac transplantation

? DESCRIPTION (provided by applicant): Ischemia reperfusion injury is an unavoidable event in organ transplantation, and it is a major clinical problem that is thought to play an important role in both short-term and long-term graft survival. The mechanisms responsible for induction of post-surgical inflammation and ischemia reperfusion injury are not well defined, although complement, and more recently natural self-reactive IgM, have been shown to play key roles in the process. We have identified neoepitopes that become expressed in cardiac grafts, and which bind natural IgM. We have prepared constructs that target complement inhibitors to a particular neoepitope, and we propose to use these constructs to study the role of IgM in immune sensing of cardiac injury and the subsequent activation of complement. Using mouse models of cardiac transplantation, as well as a series of in vitro model systems, we will investigate how various complement activation products modulate an alloimmune response and acute rejection. We will also investigate how different neoepitopes and their recognition in cardiac grafts relate to each other, and how the length of ischemia and extent of ischemia reperfusion injury relates to neoepitope expression and the priming of an alloimmune response.

Public health relevance
PUBLIC HEALTH RELEVANCE: Ischemia reperfusion injury (IRI) is an unavoidable occurrence during heart transplantation, and it can impact graft alloimmunity and survival. The goals of this project are to better understand mechanisms of cardiac IRI and the role of IRI and complement in alloimmunity. The project also aims to develop therapeutic strategies to protect against IRI and prolong graft survival.